Designing with dissemination in mind: Development and evaluation of a theory-based physical activity intervention using the Multiphase Optimization Strategy

PROJECT SUMMARY/ABSTRACT
Difficulty adhering to prescribed health behaviors significantly hinders the long-term benefits of lifestyle weight
management programs, leading to an increased risk of cardiovascular disease (CVD) and early mortality.
Although physical activity (PA) is one of the best predictors of sustained weight loss, long-term adherence to PA
remains poor in adults with overweight or obesity enrolled in lifestyle weight management programs. Absence of
accessible, effective, theory-based programs that account for each person’s values and preferences remains a
major barrier. Thus, novel, person-centered, and scalable interventions are urgently needed to effectively
promote PA adherence in adults with overweight or obesity to enhance weight loss maintenance and CVD
prevention. The overall objective of this K01 Career Development Award is to expand and pilot test a theory-
based PA program (called MOVE+) designed to enhance motivation in adults with overweight or obesity enrolled
in a lifestyle weight management program. First, I will engage stakeholders to assess the initial acceptability of
the MOVE+ intervention components. User-centered design testing will occur over 2 cycles: 1) initial stakeholder
review of MOVE+ component design and content, and 2) a 12-week, single-arm field trial to pilot test delivery of
the MOVE+ program. Second, I will evaluate the feasibility of delivering MOVE+ within an existing lifestyle weight
management program (Prevent T2). I will recruit 80 adults with BMI 25-45 kg/m2 to receive 6 months (with 12
month follow-up) of remote delivery of the Prevent T2 program, integrated with the MOVE+ program. To isolate
which MOVE+ components are “active ingredients”, I will employ the Multiphase Optimization Strategy and
conduct a cluster randomized 2^3 full factorial pilot trial. Eight clusters of n=10 participants will be randomly
assigned to a combination of 3, MOVE+ components. My long-term goal is to develop an independent research
program that focuses on the prevention and treatment of chronic diseases, including obesity and CVD, by
designing and disseminating theory-based, optimized PA interventions that promote sustained behavior change.
Along with my mentorship team (Drs. Catenacci, Masters, Kwan, Conroy, Pfammatter, Pyle, and Ms. Barnard),
I have developed a comprehensive training plan to support this career goal. My primary training goals include to
develop expertise in: 1) the application of behavior change theory to PA intervention design, 2) dissemination
and implementation science, 3) the use of novel frameworks and efficient trial designs, and 4) human clinical
trial design and conduct. My past experience, complemented by my expert mentoring team, a robust training
plan, and an exceptional environment (the University of Colorado Anschutz Medical Campus) will ensure my
success. Completion of this K01 will generate critical preliminary data needed to support a competitive R01
application and will serve as both a superb training opportunity and as an original and meaningful scientific
contribution to propel my career goal of becoming an emerging leader in PA and obesity research.

Public health relevance
PROJECT NARRATIVE The limited success of our current approaches to improve long-term physical activity adherence in adults with overweight and obesity is a substantial barrier to effectively address the current obesity epidemic and prevention of cardiovascular disease. This mentored K01 application addresses the significant public health issue of obesity by expanding and pilot testing a theory-based physical activity program designed to enhance motivation in adults with overweight or obesity enrolled in a lifestyle weight management program. The proposed research is relevant to public health because it will improve long-term physical activity adherence, which will enhance health and reduce chronic disease risk, for the large number of U.S. adults who struggle with obesity and its adverse health consequences.